SOUTHERN CA CONFOCAL MICROSCOPY USERS GROUP ADVANCED CONFOCAL IMAGING WORKSHOP

The Optical Biology Shared Resource of the Clinical Cancer Center, along with the Laser Microbeam and Medical Program (LAMMP) and BIO-RAD hosted an advanced confocal imaging workshop. There were 100 trainees in attendance.